In Vivo Efficacy Testing Core

Abstract: Core C
In vivo efficacy testing is an essential part of medical countermeasure (MCM) development. For
hemorrhagic fever viruses (HFV), where human clinical trials are difficult or unethical to conduct,
the Food and Drug Administration (FDA) instituted the animal rule. Licensure via the FDA animal
rule requires efficacy testing in at least two surrogate animal models of human disease. In support
of overall Prometheus objectives, Core C will execute in vivo efficacy testing of antibody-based
MCMs derived from Projects I, II, and III in rodent and nonhuman primate (NHP) models of
filovirus, hantavirus, and nairovirus disease. Rodent models of ebolavirus, hantavirus, and
nairovirus disease will serve as the first in vivo screening mechanism to down-select monoclonal
antibody (mAb)-based MCMs for further assessment in higher animal models. Hamster models
of hantavirus infection and mouse models of CCHFV infection will be utilized to evaluate newly
discovered mAbs from Project I and down-select lead mAbs for NHP testing. Core C will evaluate
in vivo efficacy of mAbs with altered Fc effector functions from Project II in rodent models of
disease to identify mAb modifications with optimal in vivo potency. The prophylactic efficacy of
Project III DMAbs expressing ebolavirus, hantavirus, and CCHFV-specific mAbs will be evaluated
first in rodent models of disease and lead DMAbs will be tested in NHPs. In vivo efficacy results
from all Core C efforts will be funneled into Projects I, II, and III and Cores A and B for
identification of lead mAb cocktails and/or DMAb constructs for advanced development
discussions.

Public health relevance
Project Narrative: Core C Ebolaviruses, hantaviruses, and nairoviruses cause fatal hemorrhagic fever in humans and there are currently no approved medical countermeasures (MCM) for any of these viruses. Due to high lethality and sporadic nature of hemorrhagic fever virus outbreaks, human clinical trials are unethical and impractical to conduct. Consequently, novel MCM development requires the use of surrogate animal models. Core C will support the Prometheus consortium by completing prophylactic and therapeutic efficacy testing of novel MCM developed by Projects I, II, and III in rodent and nonhuman primate models of disease.